MSKCC BMT CTN Renewal

Project Summary/Abstract
The mission of the Blood and Marrow Transplant Clinical Trials Network (BMT CTN) is to “advance
hematopoietic cell transplantation (HCT) for patients with rare and difficult to treat blood diseases through high-
quality multi-center clinical trials by evaluating new ways to improve traditional HCT approaches or by
advancing HCT therapy through the use of either novel ex vivo manipulated cell products or genetically-
modified cells.” Memorial Sloan Kettering Cancer Center (MSK) is an NCl-designated Comprehensive Cancer
Center with one of the largest HCT programs in the country. The HCT program at MSK is FACT-accredited
program and divided into pediatric and adult services. MSK has been a Core Member of the BMT CTN since
its inception and Dr. Perales (Deputy Service Chief, grant PI), Dr. Giralt (Adult BMT Service Chief, former PI)
as well as all members of the Adult BMT Service consider participation in the BMT CTN an integral part of their
mission. In this grant, we detail our ongoing commitment to the success of the Network through the formation
of an oversight structure that includes a BMT CTN MSK Executive Committee, a BMT CTN Protocol
Management Team, and a BMT CTN Internal Advisory Board. These three administrative structures leverage
not only the senior leadership of the clinical services in the Division of Hematologic Oncology, but also some of
MSK's most outstanding scientists and investigators. We are also committed to continue to provide leadership
to the Network with the next generation of innovative trials and correlative studies. In particular, we propose a
multicenter randomized phase II trial to determine the safety and efficacy of post-HCT administration of CD19
targeted chimeric antigen receptor (CAR) T cells in patients undergoing high-dose therapy followed by
autologous HCT (HDT-AHCT) for relapsed/refractory (rel/ref) DLBCL. We propose 3 specific aims: (1)
Demonstrate that MSK has the clinical and translational expertise, and capabilities in novel cell therapies,
genetically-modified cells, and early phase trials to fulfill the obligations of a BMT CTN Core Clinical Center
that will move forward the BMT CTN mission and goals; (2) Complete a phase II study in which rel/ref DLBCL
patients will receive 3 monthly infusions of CD19 CAR T cells after HDT-AHCT. In Arm 1, the 1st infusion will be
day +3 after HCT, with later infusions on days +30 and +60. In Arm 2, the 1st infusion will be day +10, with later
infusions on the same Arm 1 schedule. The primary endpoint will be PFS at a 1-year. A pick-the-winner design
will be used for the study; (3) Assess quantitative persistence and qualitative function of CAR T cells and
correlate to: serum cytokine profiles, B cell aplasia, and clinical outcomes. This research is significant as it
proposes a novel treatment paradigm in patients with relapsed DLBCL resistant to standard-dose 2nd-line
chemotherapy, who typically would have long-term EFS with HDT-AHCT of only 10-15%. The proposed study
is highly relevant to the BMT CTN, since it presents an innovative cell therapy, u s i n g genetically modified
cells to improve outcomes in patients with advanced lymphoid malignancies, including rel/ref DLBCL.

Public health relevance
PROJECT NARRATIVE Patients with relapsed diffuse large B cell lymphoma (DLBCL) that is resistant to standard-dose second-line chemotherapy have poor outcomes after autologous hematopoietic stem cell transplant (AHCT) with long-term event-free survival of only 10-15%. CD19-specific chimeric antigen receptor (CAR) gene modified T cells have shown very promising results in patients with relapsed acute lymphoblastic leukemia and encouraging results in a pilot study performed at our center in lymphoma patients who received T cells after AHCT. The proposed randomized trial will build on this experience and demonstrate the effectiveness of adoptive cell therapy with CD19 CAR modified T cells after AHCT in patients with relapsed/refractory aggressive DLBCL, identifying the best infusion schedule that will move forward to a potential future registration trial in patients with DLBCL undergoing AHCT.